Tracking the Rapid Evolution of Sex Chromosome Palindromes and Their Genes

ABSTRACT
In many species, genes and genomic regions involved in male fertility evolve rapidly. Mammalian sex
chromosomes are enriched for rapidly evolving large palindromic sequences harboring testis-specific genes.
However, the mechanism driving rapid evolution of X- and Y- palindromes and their associated genes is poorly
understood. I propose that intra-palindrome gene conversion – the “copying” of sequence from one palindrome
arm to the other via recombination – is the primary mechanism driving X- and Y- palindrome evolution. The
premise of this proposal is based upon observations from my recently published findings in mouse and previous
studies in primates that X- and Y-palindromes, respectively, undergo on-going intra-palindrome gene conversion.
To address the rapid evolution of X- and Y-palindromic sequences, I will first identify whether selective pressures
(i.e. positive or purifying selection) influence the sequence evolution of X- and Y- palindromes in mice. This will
be the first systematic analysis of both X- and Y-palindrome sequence evolution within a single species to
understand the selective pressures governing their evolution. I will also develop a novel assay to address, for
the first time, the in vivo frequencies of X- and Y- intra-palindrome gene conversion. Understanding the evolution
of X- and Y- palindromes and in vivo frequencies of intra-palindrome gene conversion will provide valuable
insights into the rapid evolution of genomic regions important for male fertility.

Public health relevance
PROJECT NARRATIVE Mammalian sex chromosomes are enriched for rapidly evolving large palindromic sequences harboring genes essential for male fertility. The mechanism underlying the rapid evolution of X- and Y- palindromes and their genes is poorly understood due to a lack of systematic evolutionary and in vivo studies. My proposed experiments will address the mechanism of X- and Y- palindrome evolution with important implications to our understanding of male infertility.